Molecular Mechanisms of Retroviral Gag-RNA interactions in Virus Assembly

Abstract
Retroviruses are positive-sense, single-stranded RNA viruses that cause cancers and severe
immunodeficiency diseases in animals and humans, including human immunodeficiency virus. Gag, the major
structural protein of retroviruses, orchestrates the assembly of virus particles that bud from the plasma
membrane of infected cells. To initiate particle assembly, Gag selectively binds unspliced viral RNA as the
source of genomic RNA in virions. This proposal focuses on the mechanism by which Gag selects genomic
RNA, addressing fundamental, unanswered questions in the field: (i) where in the cell does the initial contact
between Gag and unspliced viral RNA occur; (ii) how does Gag selectively recruit unspliced viral RNA for
packaging when it comprises only ~1% of the total RNA in an infected cell; and (iii) what are the properties of
Gag-viral RNA complexes that promote transport through the cell to the plasma membrane for particle
release? Because virus particles bud from the plasma membrane, it was originally thought that initial Gag-
genomic RNA interactions occurred in the cytoplasm. Our laboratory discovered that RSV Gag undergoes
nuclear trafficking, which is required for efficient genomic viral RNA packaging. This finding raised the
possibility that Gag binds genomic RNA in the nucleus, which challenges the dogma for how retroviruses
package their genomes.
Our imaging and biophysical studies have revealed that the RSV Gag protein forms discrete foci in the
nucleus, cytoplasm, and at the plasma membrane that have properties of biomolecular condensates (BMCs),
which have been shown to be important in regulating cell biology processes and virus-host interactions. We
have observed that the Gag nuclear foci colocalize with unspliced viral RNA, suggesting that RSV Gag initially
binds genomic RNA in the nucleus. In Aim 2 of this funded project, we are using biophysical approaches to
examine whether Gag-genomic RNA complexes exhibit properties of BMCs and undergo liquid-liquid phase
separation. In addition, we are testing the hypothesis that Gag forms BMCs with cellular transcription factors
including Mediators and RNA polymerase II to facilitate genomic RNA packaging and virion assembly. The
equipment being requested in this administrative supplement, the SpectraMax® Paradigm® Multi-Mode
Microplate reader with accompanying cartridges, will be used to perform the biophysical experiments described
in Aim 2. This equipment will allow us to perform state-of-the-art, high throughput, quantitative assays to
accomplish the goals of our approved experimental plan and publish the highest impact manuscripts.

Public health relevance
Project Narrative Retroviruses are positive-sense RNA viruses that cause cancer and severe immunodeficiency diseases in humans and animals. To spread infection, retroviral RNA is encapsidated into new virus particles released from the cell through budding from the cell membrane. This research project uses advanced microscopic imaging and biophysical methods to dissect the mechanisms of retrovirus assembly with the goal of identifying new strategies to disrupt the production of new virus particles.